ASSESSMENT OF POTENTIAL TREATMENTS FOR DRUG-INDUCED RESPIRATORY DEPRESSION AND OVERDOSE TOXICITY. POP: SEPTEMBER 26, 2022 - MARCH 25, 2023. TASK ORDER

The objectives of this project are to determine the effects of experimental compounds on respiratory parameters in rodents or other species in models relevant to the opioid overdose crisis. Compounds may be tested alone for effects on respiration (stimulation or depression), or for their ability to modulate respiratory depressant effects of opioids and possibly other drugs of abuse.